Dev-Res-Prog-001

The objective of the Glioma SPORE Developmental Research Program (DRP) is to identify innovative pilot
research projects in glioma that have translational potential. The DRP utilizes a solicitation and review process
to select meritorious pilot projects for funding. The solicitation process capitalizes on an established, extensive
Dana-Farber/Harvard Cancer Center (DF/HCC) communications infrastructure to widely disseminate an annual
Request for Proposals (RFP). The review process utilizes an experienced panel of DF/HCC glioma scientists.
The DRP provides limited-duration funding for innovative projects that have ultimate translational potential and
could synergize with existing SPORE projects and cores. DF/HCC institutions match DRP funding from this
SPORE to expand the pool of DRP awardees. The DRP applications are judged for their potential as pilot or
collaborative studies that will generate feasibility data and for their ultimate potential to emerge as full projects
in future years of the SPORE program. The DRP employs a monitoring process to measure progress and
outcomes of DRP projects including the possible elevation of successful DRP awards to full projects. The
program is closely monitored through clearly established metrics and oversight by the DRP Awards
Committee. DRP awardees are required to present biannual progress reports.

Public health relevance
The Developmental Research Program supports innovative pilot studies that will generate feasibility data and that have the potential to emerge as full SPORE projects with possible future benefit for brain tumor patients.